9th World Workshop on Oral Health & Disease in AIDS - Translating Knowledge to Improve Equitable Oral Health

The International Association for Dental Research, (DBA International Association for Dental, Oral, and
Craniofacial Research) (IADR), intends to facilitate the attendance and active participation of the most
promising graduate students, postdoctoral trainees, and early career faculty at the 9th World Workshop on Oral
Health & Disease in AIDS – Translating Knowledge to Improve Equitable Oral Health (WW9). Despite
advances in HIV/AIDS prevention and treatment, communities such as at-risk populations of men who have
sex with men, transgender people, sex workers, people who use drugs, and adolescents, still lack access to
HIV/AIDS prevention, treatment, and care services that they need due in part to HIV-related stigma and
discrimination which impedes the current response to HIV/AIDS around the world.
Specific Aims:
1. To provide an overview of current trends and strategies of prevention and treatment in the management
of AIDS patients with special emphasis pertaining to oral health and disease.
2. To identify research gaps where further research would lead to new and exciting translational
approaches and successfully contribute to the global research agenda in the field.
3. To address oral health and disease in high-risk populations including transgender communities.
4. To provide a means by which researchers at the earliest stage of their careers are exposed to the most
recent HIV/AIDs research findings from around the world.
WW9 will appraise the advances in HIV/AIDS research since the last conference in this series and is a unique
opportunity to integrate and share recent HIV/AIDS research from all parts of the world. No other meeting
provides researchers in fields related to the oral aspects of HIV infection the chance to meet in such a convivial
setting. The workshop's intent is to bring together oral health clinicians and investigators to share worldwide
perspectives, knowledge and understanding of oral health connected to HIV/AIDS; and to identify research
gaps considering worldwide perspectives and opportunities.
This funding request is to provide travel support for early career investigators to participate in the workshop
that will help to shape the future of HIV/AIDS oral research. It is anticipated that those receiving support from
this conference grant will take the knowledge acquired at the workshop back to and apply it in their own
programs, thus contributing to HIV/AIDS research, care, and education in their own countries.
WW9 proceedings will be submitted for publication and will summarize research priorities for the future of the
field. The proceedings from WW9 will serve as an invaluable tool for funding agencies, institutions, scientific
societies, and individual investigators in the field of oral health and HIV/AIDS research.

Public health relevance
Project Narrative Many communities such as at-risk populations of men who have sex with men, transgender people, sex workers, people who use drugs, and adolescents, still lack access to HIV/AIDS prevention, treatment, and care services that they need due in part to HIV-related stigma and discrimination which impedes the current response to HIV/AIDS around the world. WW9 will appraise the state of the science, foster research collaborations, share resources and findings with early career investigators, and identify research gaps, with special attention to the oral health care and disease in high-risk populations including transgender communities. It is anticipated that those receiving support from this grant will take the knowledge acquired at the workshop back to and apply it in their own programs, thus contributing to HIV/AIDS research, care, and education in their own countries.